Measuring impairment of extracellular solute transport in Alzheimer's disease

Project summary/abstract
The extracellular space (ECS) of the brain consists of a highly interconnected network of narrow tunnel and
sheet-like structures with width of 10-80 nm. Perivascular spaces surrounding blood vessels connect with the
ECS and act as conduits for transport of solutes throughout the parenchyma and to the CSF at the surface of
the brain. Nutrient delivery to tissues, clearance of toxic protein aggregates and therapeutic delivery to targets
require transport through the ECS and considerable uncertainty exists regarding the rates and mechanisms of
transport in vivo. Specifically, neither the rate, direction or regulation of solute transport in the perivascular
spaces are well understood. Recently, we demonstrated that multiphoton fluorescence recovery after
photobleaching (MP-FRAP) of exogenous fluorophores introduced into the ECS can be used to directly
measure solute transport rates deep within the brain parenchyma in vivo. Experiments to be performed here
will adapt this technique to measure the rates and direction of perivascular solute transport in mouse brain and
thereby resolve basic questions regarding the physiology of these spaces. In Alzheimer’s disease (AD),
amyloid plaques form in the parenchyma and around blood vessels, causing extensive changes in structure
and function of the surrounding glia. The consequences of these changes for transport of solutes in the
perivascular space remain largely unknown and we will utilize AD model mice to determine if deposition of Aβ
around vessels impairs perivascular solute movement. It is hoped that these experiments will lead to a
quantitative and well substantiated understanding of perivascular extracellular transport in the brain, and
suggest approaches for enhancing endogenous clearance mechanisms and improving therapeutic delivery.

Public health relevance
Project narrative Impaired clearance of toxic proteins from the brain to the cerebrospinal fluid is proposed to contribute to the pathology of Alzheimer’s disease but it is not known where and how clearance is impaired. Here, we propose to develop a novel imaging methodology to directly measure protein transport in specific locations within the brain and use it to determine how clearance of toxic protein aggregates is impaired in Alzheimer’s disease. Results of these studies are expected to directly impact diagnosis and treatment of Alzheimer’s disease by improving understanding of biomarker data, enhancing drug delivery methods and contributing to the development of therapies that increase clearance of toxic proteins.